Targeting YAP with statins to prevent antibody-mediated transplant rejection

ABSTRACT
Solid organ transplant recipients exhibiting HLA donor specific antibodies (DSA) are at risk for graft loss due
to chronic antibody-mediated rejection (cAMR) and develop a progressive vascular disease known as
transplant vasculopathy (TV). Although cAMR and TV are highly significant clinical problems across different
solid organ transplants the mechanisms by which DSAs directed against HLA I and HLA II contribute to cAMR
and TV are not yet understood. Previously, we demonstrated that DSA-induced ligation of HLA molecules
expressed in the surface of ECs induces signaling pathways, including FAK/Src, PI3K/AKT, mTORC1/2 and
ERK that regulate survival, proliferation and migration, all of which are highly relevant to TV. However, the key
transcriptional programs stimulated by these signals remain to be identified. Based on new preliminary results,
we posit that the transcriptional co-activator Yes-Associated Protein (YAP) and its paralog WW-domain-
containing Transcriptional co-Activator with PDZ-binding motif (TAZ), two central effectors of the Hippo
pathway, are downstream points of convergence in the signaling cascade initiated by DSAs. Although inhibition
of the activity of transcription factors or their co-activators is a challenging strategy, recent evidence suggests
a new avenue to target YAP/TAZ activity via lipid-lowering drugs of the statin family. Importantly,
epidemiological studies strongly indicate that statins exert a beneficial effect in clinical transplant populations.
However, the molecular mechanism remain poorly understood. This gap in understanding hinders effective
therapeutic targeting of DSA effector functions to prevent cAMR and TV. The central hypothesis of this
proposal is that YAP and its paralog TAZ play a crucial role in promoting the proliferation and migration of ECs
in response to DSAs. A second hypothesis is that the FDA-approved drugs of the statin family inhibit YAP
function in these cells. Thus, drugs of the statin family can be an important element in preventing cAMR via
blocking growth-promoting YAP/TAZ signaling in ECs. We will explore these hypotheses by pursuing three
Specific Aims: 1) Determine the regulation and function of YAP in human ECs stimulated with antibodies
directed against HLA I or HLA II: role of Src kinases. 2) Define the mechanism(s) by which statins inhibit YAP
function, proliferation and migration of ECs stimulated with antibodies directed against HLA I or HLA II. 3)
Characterize the impact of statins on YAP and cAMR in vivo using a novel model of heart graft allograft that
develop TV. We anticipate that the YAP/TAZ axis plays a critical role in antibody-mediated EC proliferation
and that statins inhibit EC proliferation and TV via YAP/TAZ inhibition. If the experimental results substantiate
our hypotheses, YAP/TAZ will emerge as novel targets for developing new and potent drugs for preventing
chronic allograft injury induced by DSAs.

Public health relevance
PROJECT NARRATIVE Characterization of the transcriptional co-activator Yes-Associated Protein (YAP) and its paralog WW-domain- containing Transcriptional co-Activator with PDZ-binding motif (TAZ), two central effectors of the Hippo pathway, as downstream points of convergence in the signaling cascade initiated by anti-donor HLA antibodies (Ab) will permit us to establish mechanisms underlying how HLA Ab promote endothelial cell (EC) growth contributing to chronic antibody-mediated rejection (cAMR). We will also determine if FDA-approved drugs of the statin family inhibit YAP function in HLA Ab-activated ECs providing evidence that drugs of the statin family can be an important element in preventing cAMR via blocking growth-promoting YAP/TAZ signaling in ECs.